NIH StrokeNet National Data Management Center (NDMC)

Stroke is a disabling and often fatal disease that affects all ages, but mostly in the elderly. Stroke incidence
is expected to rise in the US as its population ages. Therefore, its impact on public health and health resources
utilization will continue to be significant. The Stroke Progress Review Group and the National Institute of
Neurological Disorders and Stroke (NINDS) have identified a need for a network of stroke clinical trials centers
in order to prioritize and efficiently design and conduct exploratory (Phase II) clinical trials and confirmatory
(Phase III) clinical trials to identify and advance stroke treatments. The NIH StrokeNet is a multidisciplinary
stroke research infrastructure that includes a National Clinical Coordinating Center, a National Data Management
Center (NDMC), 25 Regional Coordinating Centers and the NINDS. Its mission is to develop and test new
therapies for stroke treatment, recovery, and prevention that can decrease the global burden of stroke.
The NDMC’s role is to establish a collaborative relationship with all parties involved in the Network and
provide efficient and standardized central data management that yields high quality data and statistical support
in the planning and execution of the stroke trials. To this end, the Data Coordination Unit (DCU) at the Medical
University of South Carolina has developed a web-based comprehensive integrated electronic data capture and
clinical trials management system, WebDCU™, that enables data entry from the participating clinical sites with
extensive data quality control and that provides the necessary tools to efficiently manage operational activities
for concurrent multiple trials, while ensuring compliance with the NINDS Common Data Elements and FDA
guidance and regulations. Using the WebDCU system, we have developed, implemented and maintained a
central database that streamlines and maximizes efficiency in the management of data collection, processing,
and monitoring of clinical, biomarker and neuroimaging data. In addition, the WebDCU™ incorporates trial
management information system that provides full support for all study operational activities in the StrokeNet.
The neuroimaging repository at the NDMC houses protocol designated imaging that requires central review for
all StrokeNet trials. In addition, in collaboration with the study Principal Investigator and other parties of the
StrokeNet, the NDMC biostatisticians: contribute to the innovative and efficient protocol development (including
study design and case report forms development); statistically monitor study progress; generate reports for the
DSMB and the study teams; conduct interim and final analysis; disseminate study results via presentations and
publications; and create public use data sets for data sharing when a study is completed.

Public health relevance
The NIH StrokeNet is a research network infrastructure to efficiently conduct clinical trials to identify intervention for: (1) acute treatment of stroke; (2) prevention of stroke recurrence; and (3) recovery and rehabilitation after stroke. The National Data Management Center (NDMC) of the NIH StrokeNet offers economies of scale through its centralized clinical management system to conduct multiple stroke clinical trials simultaneously and efficiently. This is expected to have an impact on the public health by potentially reducing stroke occurrences and the burden of stroke to the individuals as well as to the society.